Hormetic ER Stress Regulation of Hematopoietic Stem Cell Function

Project Summary
Hematopoiesis involves the continuous production of red blood cells (erythrocytes), immune cells (leukocytes)
and blood clotting platelets over the lifespan of the subject all of which are derived from hematopoietic stem cells
(HSCs) located in bone marrow. HSCs have two critical characteristics - multipotency and self-renewal. A
complete picture of the molecular mechanisms regulating homeostatic output of blood from HSCs in vivo has
not yet emerged. Our published findings show HSCs are endowed with low intracellular calcium (Ca2+)
compared to bone marrow (BM) progenitor and lineage cells. We hypothesized a reduced extracellular calcium
environment, such as a low CaCl2 culture media, might improve HSC function. Remarkably, reduced CaCl2
media dramatically increased phenotypic HSC counts in long-term cultures and demonstrated a 20-fold increase
in long-term donor engraftment compared to classical CaCl2 media formulation, suggesting functionally potent
HSCs are maintained in low CaCl2. We demonstrated that HSC maintain low Ca2+ levels via high expression
and activity of plasma membrane calcium efflux pumps (PMCA) and reduced bone marrow interstitial fluid CaCl2
levels. Reduced CaCl2 decreased mitochondrial respiration, but not glycolysis, specifically in HSCs, while
inhibition of glycolysis elevated HSC Ca2+. These results demonstrate a positive feedback mechanism whereby
glycolytic PMCA Ca2+ efflux activity reduces Ca2+ and prevents mitochondrial respiration and promotes
glycolysis. Curiously, we showed mitochondrial mass is highest in HSCs suggesting an important, albiet
respiration-independent, role in HSCs. Building on these findings, literature suggests reduced CaCl2 can induce
ER stress. We observed Bcl-2 exhibits a dose-dependent upregulation under reduced CaCl2 culture conditions
in HSCs, suggesting induction of a pro-survival gene program. Regulators of the antioxidant genes known to be
induced by ER stress, including ATF4 and Nrf2, mediate upregulation of antioxidant genes including Bcl-2. We
found ATF4 and Nrf2 were also high expressed in HSCs in low CaCl2 culture. Therefore, we hypothesize that
reduced CaCl2 induces a hormetic ER stress response that supports HSC maintenance in vitro. We propose to
study what types of ER stresses occur and which unfolded protein response (UPR) signaling path branches are
activated in response low CaCl2. We propose to characterize the transcriptional program regulated by the PERK
branch of UPR, which activates the Atf4/Nrf2 ER stress response programs, that we have identified to be active.
Further, we propose to study the upregulation of Bcl-2 in HSCs under low CaCl2 conditions to determine if a
non-canonical role for Bcl-2 inhibits IP3R release of Ca2+ from luminal ER Ca2+ stores in HSCs. Furthermore,
we propose to corroborate these findings in human CB HSCs to accelerate translational potential of the findings.
This would establish a novel positive feedback loop required to reduce Ca2+ levels and preserve self-renewal
and multipotency in HSCs. These findings will expand our fundamental understanding of HSC biology and may
inspire methods to improve HSC expansion for clinical applications.

Public health relevance
Project Narrative The processes controlling blood stem cell regeneration remain poorly understood and appear to change over a person’s lifetime as diseases of the blood are associated with abnormal production as blood stem cells age. Blood cancers are treatable through transplantation of young, healthy blood stem cells but the availability of compatible donors and the inability to expand patient-specific blood stem cells in tissue culture makes blood stem therapy limited. The goal of this research will be to broaden our understand the basic requirements needed for blood stem cells and if low calcium conditions impact stem cell function to aid future attempts to improve the sources of blood stem cell to ultimately increase the availability of healthy blood stem cells available to patients with terminal diseases.